Training Program on Innovative Approaches to Spinal Cord Injury

Training and mentoring students (post-baccalaureate and graduate) from populations and
communities underrepresented in biomedical science research is a key component to the success
of the parent T32 grant (Training Program in Innovative approaches to Spinal Cord Injury). The
faculty member who is responsible for Diversity training for the T32 would like to attend the
upcoming workshop NINDS R25/T32 Biennial Workshop titled "Sustaining a Neural Network:
Fostering an Inclusive Research Culture” to be held on April 29-30, 2024 in Washington DC.
Therefore the PI, Dr Peter Baas is requesting a supplement award to cover the cost for Dr
Raghupathi to attend this workshop. By attending the workshop with a view to networking with
successful training grant awardees and meeting with NINDS program staff, Dr. Raghupathi seeks
to be educated on strategies that will contribute to successful funding of R25 grants for Drexel
University that will be aligned with the funded T32 grant. Importantly, Dr Raghupathi hopes to
gain information on improving recruitment and retention efforts that will directly benefit the
funded T32 grant.

Public health relevance
We are responding to the NINDS Diversity Training Team’s email of January 12, 2024 to request supplemental funding of $521 for Dr. Ramesh Raghupathi’s travel costs to attend the NINDS R25/T32 Workshop, "Sustaining a Neural Network: Fostering an Inclusive Research Culture.”